Mechanisms of cannabinoid-resistance among oral spirochetes

PROJECT SUMMARY
Periodontitis, a microbial-driven, destructive disease of the tissues surrounding the teeth, occurs in
approximately 50% of the population and is associated with several debilitating systemic conditions,
including vascular and lung diseases, diabetes mellitus, pre-term birth, specific cancers and
Alzheimer’s disease. Patients who smoke marijuana have increased susceptibility to periodontitis.
Indeed, the most recent epidemiological evidence suggests that marijuana both exacerbates the
severity of disease and induces periodontal disease at a significantly younger age than is normal. One
key predisposing mechanism is likely to be the induction of a disease-related dysbiotic plaque by
cannabis. Based on a preliminary study of the oral microbiome of cannabis users and non-users, we
have shown that – unlike many oral bacteria – Treponema putidum and multiple strains of Treponema
denticola are resistant to physiological and supraphysiological doses of the primary anti-microbial
phytocannabinoids (CBN, CBD, THC). We have also identified CBD-regulated genes involved in
transcriptional regulation and toxin control that help explain such resistance in the T. denticola type
strain, ATCC 35405. We now plan to extend these studies by (Aim 1) identifying further
phytocannabinoid resistant oral spirochetes; delineating their individual responses to
phytocannabinoid-induced stress; and generating the first oral spirochete pantranscriptome in the
context of the spirochetal pangenome. Thus, we will identify species-specific and global, pan-
spirochetal CBD-related resistance and virulence traits. In Aim 2 we will generate mutants (and
complemented strains) in ubiquitously CBD-regulated genes and assess their cannabinoid-related
fitness thus facilitating future, in depth comparative fitness and other mechanistic studies at the R01
level.

Public health relevance
PROJECT NARRATIVE Cannabis use has recently emerged as a major risk factor for destructive periodontitis (gum disease) although the underlying mechanisms are unknown. We plan to characterize, for the first time, how a key group of pathogens - the oral spirochetes - survive exposure to the major anti-bacterial components found in marijuana smoke (the phytocannabinoids) while other periodontal bacteria do not. This will provide some of the first information to facilitate a better understanding of marijuana- bacterial interactions and their relevance to a highly prevalent human disease.